The role of histone tails in chromatin structure and gene regulation

Project Summary/Abstract:
The dynamic regulation of chromatin is critical for proper gene expression, and dysregulation leads to diseases
including cancer and metabolic disorders. The basic subunit of chromatin is the nucleosome, which is formed by
a histone protein core around which DNA wraps. The unstructured histone termini, referred to as histone tails,
protrude from this core and are key players in chromatin regulation. Incorporation of histone post-translational
modifications (PTMs, chemical or protein modification of histone residues) and histone variants (histones with
distinct sequences that substitute for canonical histones) are two major mechanisms of chromatin regulation,
and they act in part through the histone tails. Despite great strides being made in understanding the chromatin
landscape, large gaps remain in our knowledge of chromatin structure, gene regulation, and the histone
language. The long-term goal of the laboratory is to define the chromatin landscape (the complex molecular
interactions within and between nucleosomes along with their genetic and epigenetic factors) that underlies gene
expression so that dysregulation that causes human disease can be corrected. The objective is to develop a
molecular-level understanding of the conformation and dynamics of the histone tails within the nucleosome along
with their bridging interactions (altogether, the histone tail landscape) and how these translate to the level of
chromatin structure and accessibility. This includes determining how histone tail landscapes are perturbed by
histone post-translational modifications and histone variants and how these landscapes are interconnected with
each other and those of other nucleosome components. In this five-year MIRA proposal, the focus will be on: 1)
determining how lysine acylations differentially regulate the histone tail landscape to contribute to metabolically-
linked differential gene regulation, and 2) the variant-specific role of the centromeric H3 variant in regulating
chromatin structure during mitosis and chromosome stability. A pairing of solution NMR spectroscopy with other
biophysical approaches and phase separation studies, as proposed here, is essential to decipher this highly
dynamic and heterogeneous system. Understanding the structural and dynamic effects of histone PTMs and
variants on regulatory control of gene expression and chromatin structure will lead to a significant enhancement
in our understanding of fundamental mechanisms of gene regulation and epigenetically-linked diseases.

Public health relevance
Project Narrative: The proper temporal and spatial regulation of chromatin is key in human development and health, and dysregulation leads to diseases such as diabetes, cancer, heart disease, and developmental, neurological, and immunological disorders. The proposed research project will further our understanding of the molecular mechanisms that alter the structure and accessibility of chromatin. These studies will contribute to fundamental knowledge about mechanisms of gene regulation and how dysregulation leads to disease states.